Innovative Tools for Chemical Synthesis: Metal-Hydride Catalysis, Medicinal Motifs, and Molecular Probes

Principle Investigator/Program Director (Last, first, middle): Dong, Vy, M
Project Summary/Abstract
Asymmetric transition metal catalysis has proven time and time again to be a crucial strategy in the
pharmaceutical industry. The development of novel methods for accessing common organic scaffolds with
improvements in the areas of atom-economy and selectivity has supported the mass production of valuable drug
molecules. Hydroacylation is a powerful catalytic tool in which a hydrogen and an acyl group are added across
a site of unsaturation via transition metal catalysis. This has the potential to be useful in the construction of
carbonyl motifs for synthetic drug discovery. Azetidines are four-membered cyclic amines that can be found in
drug candidates and natural products such as Nicotianamine and Ximelagatran. Our goal, described herein, is
to explore the potential for a Rh-catalyzed asymmetric hydroacylation of azetines to generate novel azetidine
scaffolds. Switching the ligand of choice, chiral Josiphos versus 1,2-bis(diphenylphosphino)ethane dppe, allows
a regiodivergent strategy for the construction of chiral azetidines and achiral compounds. Building off of this
work, we also aim to develop further hydroacylation methods to gain access to several other strained ring
systems, which have been found to provide favorable structural and physicochemical properties necessary for
molecular optimization in modern medicinal chemistry.

Public health relevance
Principle Investigator/Program Director (Last, first, middle): Dong, Vy, M Project Narrative Transition metal catalysis has significantly transformed the methods in which medicines are discovered and prepared. This can be seen through Nobel prize-winning work on asymmetric hydrogenation, metathesis, and C-C coupling reactions. There remains a conscious effort to produce enantioselective transformations that occur with high selectivity and atom-economy in order to furnish enantioenriched biomolecules. By use of transition metal catalysts, chemists have uncovered the functionalization of C-H bonds that previously were deemed inert. A particular motif of interest for small-molecule and natural product design are nitrogen-containing heterocycles. These strained ring systems such as cyclopropenes, azetidines, and cyclobutanes, all have been exploited in medicinal chemistry for their physicochemical properties and applications as functional group bioisosteres. Our program has a strong interest in utilizing the transformative power of hydroacylation—a process where C-H bond activation occurs with C-C bond formation, to introduce a creative method for resolving chiral strained rings. This work would not only develop more efficient methods to access such privileged motifs, but simultaneously open the door to future synthetic strategies in this chemical space.